2025 Biology of Aging Gordon Research Conference and Seminar

PROJECT SUMMARY
This application requests funds to support the 2025 Gordon Research Conference (GRC) on the Biology of
Aging, to be held at the Renaissance Tuscany Il Ciocco in Barga (Italy) on August 3 – 8, 2025, and the Gordon
Research Seminar (GRS), which will be held at the same location on August 2 – 3, 2025, immediately prior to
the GRC. This will be the seventeenth Biology of Aging meeting since its origin in 1962. This meeting is unique
in its diversity, reflected in the theme of the 2025 conference: “Biology of Aging Across Scales: Molecular,
Cellular, Organismal”. Over recent decades, the field has made remarkable progress in elucidating the key
hallmarks of aging at increasingly refined molecular and cellular levels. These advances have fostered a
paradigm shift in our understanding of aging, revealing it to be a malleable process amenable to intervention.
This plasticity extends beyond cellular models and invertebrates, encompassing a wide range of vertebrates and
even humans. At the same time, rapid technological innovations and the diversification of experimentally
tractable model organisms have enabled researchers to examine aging from a more holistic perspective. We
now have a far more nuanced portrait of aging, offering unprecedented insights into the intricate interplay
between the immune system, the brain, the genome, and the aging process itself. This has also opened new
avenues for potential therapeutic interventions across various biological scales. Biology of Aging GRC will
highlight some of these emerging top-down approaches to understanding aging with a focus on reproductive
aging, intertissue signaling, epi/genetics, and comparative biology.
Our goal is to remain the premier forum for coalescing the field and fostering the discussion of concepts and
presentation of unpublished research at the forefront of discovery related to systemic aging. Funds are requested
to help cover expenses of invited speakers, meritorious junior scientists and minority trainees who will benefit
from formal and informal interactions with senior scientists, to present their research findings, receive feedback
from experts in the field, and exchange ideas for shaping the field. Invited speakers include established as well
as outstanding early career scientists selected for the quality of their science and ability to stimulate debate. We
will provide a forum for both formal and informal interactions between trainees and faculty at all stages to promote
the exchange of ideas and collaborative synergies around reproductive aging. Poster and oral presentations will
examine aging at the molecular, cellular and organismal level, including its molecular drivers, and the effects of
genetic and environmental factors on relevant cellular/system properties, interactions, and interventions across
diverse model systems ranging from worms to humans. This unique conference will bring together scientists
tackling this problem from fundamental to clinical angles to brainstorm creative ways to build and strengthen the
field.

Public health relevance
PROJECT NARRATIVE If the greatest success of public health in the last one hundred years was adding years to our lives, the next challenge is to make those added years healthy. Although aging has long been appreciated as a risk factor for disease, modern medicine has largely ignored it as a therapeutic target. The goal of the Biology of Aging Gordon Research Conference is to showcase cutting-edge research and stimulate collaborations that bridge scientific disciplines across aging research to help define new paradigms to accelerate progress and define novel interventions to increase healthy longevity.